ERK-mediated regulation of non-coding RNAs during development and disease

PROJECT SUMMARY
Successful reproduction through the fusion of the sperm and oocyte is essential for the perpetuation of species.
In human females, oocytes complete meiosis I at birth, and enter a long period of meiotic II arrest until
onset of meiotic maturation at puberty. Because the oocytes are quiescent and arrested during this period,
RNAs are loaded into the developing oocytes prior to the arrest and these RNAs are critical for early
embryonic development. Mechanisms that regulate generation and protection (from degradation) of
maternal RNAs during the long meiotic arrest as well as mechanisms that regulate the degradation of these
RNAs in the embryo remain an active area of investigation. Our work in C. elegans and work from mammalian
models in the past few years turned the light on regulation of the maternal transcriptome which dictates oocyte
quality and impacts progeny development. Specifically, we uncovered a direct link between RAS/ERK growth
factor signaling and the small RNA biogenesis factors Dicer1, Drosha and DIS3 (an RNA exosomal component)
which regulates distinct populations of small non-coding RNAs and thus the maternal transcriptome and
proteome. We propose a model wherein ERK-mediated phosphorylation of Dicer1 (and a subsequent arginine
methylation of Dicer1), phosphorylation of Drosha and DIS3 results in a regulatory circuit that fine tunes the
generation of small non-coding RNAs in specific subsets and regulates the maternal and zygotic transcriptome
and proteome. We investigate this model in vivo during oocyte development and oocyte-to-embryo transition
using a combination of live imaging, next generation sequencing, single oocyte sequencing, mass spectrometric
and proteomic methods, CRISPR Cas9 genome editing and cell biological assays. We find that Dicer1, Drosha
and Dis3 are phosphorylated in mammals as well. Additionally, we identified arginine methylation of Dicer1
adjacent to the phosphorylation event in mammalian cell culture system. Given their conserved role in RNA
biology, reproduction and their aberrations associated with cancer onset and progression, we expect this work
to have direct relevance to human biology.

Public health relevance
NARRATIVE The proposal seeks to investigate the role of RAS/ERK signaling in sculpting the small non-coding RNA landscape via phosphorylation of Dicer1, Drosha and DIS3 to regulate and coordinate maternal transcriptome and proteome with oocyte-to-embryo transition and embryonic morphogenesis. Because meiosis I and role of RAS signaling is a fundamental and conserved process across metazoans, the knowledge gained from this research has implications to understanding both infertility and birth defects. Additionally, we find that ERK-mediated Dicer1 phosphorylation correlates with aggressive human endometrial cancers and unregulated phosphorylated Dicer1 activity leads to sterility in mouse models, this work will thus also inform mammalian biology.